Rolosense: An innovative platform for automatic mobile phone readout of active SARS-CoV-2 particles (RADx-rad / SEED Administrative Supplement)

Project summary:
The supplement application is in response to the RADx-rad announcement on the opportunity of
additional resources and funding support to facilitate the pathway to commercialization. As part
of this supplement we will pursue specific milestones to de-risk the Rolosense technology and
further move it toward commercialization. A major goal will be to introduce multiplexing
capabilities to simultaneously detect multiple viral targets from the same sample. Encoded
Rolosense particles with unique virus-binding ligands will be employed to achieve this goal.
Multiplexing to detect multiple viral targets will help distinguish the capabilities of Rolosense from
that of the current state-of-the-art. Another goal is to increase the speed and robustness of the
assay to facilitate direct sensing from breath condensate samples. This second goal will be
pursued by further developing fuel-free Rolosense that eliminates the need for RNA and RNaseH
enzyme in the assay. We see this as a critical step to reduce the cost of the assay and to increase
rigor and reproducibility to achieve the commercialization goals without concern for RNaseA found
in most biological samples.